Cell-resolution imaging of synapses and circuits in post-mortem specimens

PROJECT SUMMARY
Our brain's ~90 billion neurons allow us to think, move, and respond to stimuli. The brain's remarkable
properties stem from neural circuits, which perform logical operations based on both the temporal patterns of
neural activity and the spatial connectivity of neurons and astrocytes. Gaining a better understanding of the
brain's circuitry will have wide ranging implications for human health. Strategies for visualizing and controlling
neural activity abound, but there are few methods that enable direct imaging of neural circuit connectivity, and
those that exist rely of functional cell physiology, which makes them not applicable to systems that require
analysis using fixed post-mortem samples. In this application, we propose a chemical strategy that will enable
light microscopy-based imaging of neural synapses and circuit connectivity in post-mortem specimens,
including, potentially, the human brain.
Our strategy for imaging synapses and circuits employs reactive chemical groups that we target to the
neural synapse where they trigger fluorescence on connected cells. Fundamentally, this strategy is composed
of two parts: (1) the molecules that become fluorescent to reveal the connected neurons, and (2) the
molecules that are targeted to the synapse in neurons of interest to activate fluorescence in connected
neurons. The first molecules are pro-fluorescent lipids that we will use to label neuron populations of interest,
similar to the popular lipophilic neural tracers DiO and DiI. These molecules are non-fluorescent until they react
with the second component, at which point they become fluorescent. The second component is the reactive
fluorescence activator that we deliver uniformly to the membranes of the sample but is designed to only
become reactive at the neural synapse after exposure to an enzyme localized to the synapse by an antibody.
Importantly, we have recently developed the critical enabling technology: a chemical ligation reaction that can
be activated by the presence of an enzyme to produce a fluorescent product. Overall, this strategy we describe
merges aspects of immunochemistry and the classic lipophilic tracers used to chart neuron morphology, two
methods that excel in post-mortem samples. The result is a reactive neural tracer that will enable synapse
detection and circuit imaging with light microscopy in post-mortem specimens. The ability to interrogate neural
circuitry in post-mortem specimens with light microscopy will enable the field to directly assess the validity of
circuit level findings from lower organism disease models to humans.

Public health relevance
PROJECT NARRATIVE There is broad recognition that the anatomy of neural connectivity is key to nervous system function and aberrant connectivity key to disease manifestations. Nevertheless, it is very often not possible to understand exactly how, at the cellular level, normal brain circuitry functions and aberrant circuitry causes disease. Here we describe the development of a strategy for visualizing brain connectivity using light microscopy that will be applicable to specimens that are incompatible with the available genetic techniques.